Aging in Puerto Rico: Longitudinal Follow-Up of the PREHCO Study

In the past decade, Puerto Rico has experienced rapid population aging, financial collapse, mass outward migration of younger people, and then Hurricane Maria. Now is an ideal time to build on the only population-based cohort of older adults in Puerto Rico, unique in having data on health and function prior to these major events. Households across Puerto Rico were visited to identify the first island-wide sample of adults age 60+ years for the Puerto Rican Elderly: Health Conditions (PREHCO) study. A wide range of measures relevant to health and aging, including in-home testing of cognitive and physical function, was collected at baseline (2002/2003; N=4,291) and four years later (2006/2007; N=3,891). We propose to gather two new waves of data related to aging, stress and health in a sample of approximately 1,000 PREHCO survivors. The current project will a) extend PREHCO follow-up to between 16 and 20 years after baseline; b) examine life course predictors of major aging outcomes, namely cognitive impairment, disability, and mortality; c) collect data on hurricane-related stressors and mental health; d) add hair cortisol as a marker of chronic hypothalamic pituitary adrenal (HPA) axis activation; and e) add cognitive and proxy informant measures that align with the Health and Retirement Study (HRS). Our project will enable the following specific aims: Aim 1. Examine longitudinal life course biopsychosocial predictors of cognitive health, cortisol levels, mental health, disability, and mortality 16- 20 years after baseline. Aim 2. Examine cross-sectional associations between stressors, resilience-enhancing factors, perceived stress, cortisol, and health, as well as changes in health two years later. Aim 3. Increase utility of PREHCO for cross-cultural comparisons. Puerto Rico is an important part of the U.S. that has largely been omitted from U.S. population-based studies of aging. PREHCO participants are now age 76+ years and given accelerating mortality rates for this age group, our proposal to gather two new time points of follow-up data for PREHCO represents a time-limited opportunity to add to our knowledge about aging, stress, and health in an understudied and potentially vulnerable population.

Public health relevance
PROJECT NARRATIVE Research on the socioenvironmental context in Puerto Rico has been extremely limited and little is known about the pathways that link the residential environment to health among this population. This project investigates how housing, neighborhoods, health care environments, and physical hazards influence the health and well-being of older community-dwelling Puerto Ricans from the Puerto Rican Elderly Health Conditions Project (PREHCO) collected in 2002-03, 2006-07, and 2020-21. Results from the study will provide new insights into the social determinants of aging among community-dwelling older adults in Puerto Rico that can be used to inform future research as well as policies for designing communities that support aging in place, especially in the context in the aftermath of Hurricane Maria and the outmigration of younger cohorts.